Role of patient-provider communication on clinical outcomes of rehabilitation for chronic spine pain

PROJECT SUMMARY
This proposal features a comprehensive pre-doctoral program of training, mentorship, and research activities
that will provide me with the support, knowledge, and skills necessary to advance my career goals of attaining a
tenure-track faculty position at a research intensive academic medical center, and becoming an independent
research scientist as well as a leader in the field of pain communication. Training activities will be completed as
a doctoral student in the Health Behavior Track of the Joint Doctoral Program in Public Health at the University
of California San Diego (UCSD) and San Diego State University (SDSU). The overall research objective is to
build from my previous background in pain communication to better understand how communication practices
influence pain outcomes in the physical therapy management of adults with chronic spine pain. This will be
accomplished by conducting a mixed methods, longitudinal study of the relationship between communication
practices (empathic communication and up front agenda setting), patient-provider therapeutic alliance, and
clinical outcomes (pain intensity and interference) in patients referred to physical therapy for the management of
chronic spine pain. A comprehensive training plan that includes didactic coursework and practical research
experience will allow me to gain advanced knowledge and skills in the emerging field of pain communication,
including (1) clinical research and practice by working directly with physical therapists and patients with chronic
spine pain, (2) qualitative research in the field of communication to include mixed-methods approaches in the
evaluation of patient outcomes, (3) professional networking in both communication and pain management
research, (4) leadership and management by mentoring graduate and undergraduate student research
experiences, and (5) study design and analysis, project management, and dissemination of research findings.

Public health relevance
PROJECT NARRATIVE Chronic pain is among the most pervasive and costly health conditions nationally. In line with the U.S. Department of Health and Human Services’ National Pain Strategy, this proposal aims to improve the quality of pain care by examining how physical therapists’ communication practices can indirectly impact clinical outcomes in patients with chronic spine pain. The knowledge gained in this study will provide the rationale and direction for developing communication training interventions for health care providers to enhance the effectiveness of non-pharmacological strategies for pain management.